The Neglected Subiculum: Decoding and Manipulating Memory Retrieval with Multiphoton Holography

Memory impairment emerges in diverse, clinically-significant conditions spanning all stages of life. After a
memory has been encoded, its retrieval is believed to occur through the reactivation of an engram, the
physiological substrate of memory. Engrams are partitioned into neuronal ensembles—small groups of
functionally-related neurons—that are dispersed throughout the brain. Direct optogenetic stimulation of
engram cells in the hippocampus has proven sufficient to trigger the coordinated reactivation of these
dispersed ensembles. The primary output node of the hippocampus, the subiculum, has proven critical to
the integrity of memory retrieval and is robustly associated with the memory impairments observed in
Alzheimer’s disease. However, despite a rich history of memory research in the hippocampal formation, the
subiculum and its role in memory remain critically understudied. Remarkably, recent evidence indicates the
integrity of the subiculum may be critical for memory retrieval without being necessary for encoding. Identifying
the unique role of the subiculum in memory retrieval is thus a central question in memory research. To address
this gap in knowledge, I will leverage large-scale two-photon calcium imaging alongside holographic
photostimulation to decode and manipulate subicular activity during memory retrieval in mice. I will test the
hypothesis that conjunctive-coding and recurrent-modularity in the subiculum facilitate the coordinated
reactivation of neuronal ensembles during memory retrieval. I have constructed an experimental setup in
which I am able to simultaneously measure (two-photon calcium imaging) and manipulate neural activity (two-
photon holographic optogenetics) in mice during a closed-loop fear conditioning assay. I have found that
partially-overlapping neuronal ensembles in the subiculum encode a variety of task-relevant features during
retrieval, including the temporal gap between the retrieval cue and the anticipated aversive stimuli. In the F99
phase, I will test the hypothesis that the activation of subsets of the identified neuronal ensembles
preferentially drive intra-ensemble activity. To do so, I will be trained in and use two-photon holographic
optogenetics to selectively stimulate arbitrary subsets of intra-ensemble and random neurons. Simultaneously,
I will record the activity of these neurons using two-photon calcium imaging in order to determine whether
stimulation drives persistent activity on an order of magnitude longer than photostimulation duration and
whether such activity is specific to ensemble neurons. In the K00 phase, I will investigate the coordination of
subicular and cortical activity during memory retrieval, and its perturbation in disease. This proposal will
establish a causal understanding of subicular dynamics during memory retrieval, a deeper understanding of
the coordination of memory retrieval across brain regions, and nurture the development of an independent
researcher from a disadvantaged background at the cutting-edge of memory research.

Public health relevance
PROJECT NARRATIVE An understudied region of the hippocampal formation—the subiculum—has a poorly-defined, but necessary, role in memory retrieval. Subicular atrophy is one of the earliest biomarkers for Alzheimer’s disease, and is robustly associated with cognitive impairment. This proposal seeks to advance our understanding of this neglected region, determine what role it may play in the coordination of brain-wide activity, and generate critical insights into neurodegenerative disease.